Regulatory Support for Cancer Prevention Agent Development

The purpose of this contract is to provide regulatory services and technical support to the Division of Cancer Prevention (DCP) at the National Cancer Institute (NCI). This contract will prepare and maintain documents required by the Food and Drug Administration (FDA) and other regulatory bodies for clinical trials of investigational agents. Technical Support is required to gather, interpret and summarize the preclinical and clinical data associated with potential cancer preventive agents.